California National Primate Research Center

PROJECT SUMMARY
The California National Primate Research Center (CNPRC), located at the University of California, Davis, is
supported by the base operating grant #P51-OD011107 for the next five year period (May 1, 2018 through
April 30, 2023). The CNPRC has a strategic emphasis on multidisciplinary research teams that focus on the
development and use of nonhuman primate models of human health and disease. Currently in the 58th year
of operation, the CNPRC serves a range of NIH-supported investigators nationwide. From inception through
the current year, the CNPRC has been highly responsive to the research community by providing high quality
animals, facilities, tools, and services driven by the intellectual infrastructure of the Core Scientists that guide
and conduct basic and translational research with nonhuman primates. The goals for the CNPRC are reflected
in the following Specific Aims: (1) Conduct state-of-the-art research and scientifically contribute to the
understanding and treatment of human disease with nonhuman primate models across the age spectrum, (2)
Provide exceptional nonhuman primate expertise and services to investigators at the local, regional, and
national levels to advance NIH-supported research excellence, (3) Mentor and train the next generation of
translational investigators with nonhuman primate expertise, and (4) Ensure the highest standards of
responsible conduct of research and animal care. Plans for the next funding period build upon expertise,
productivity, and innovation; strong ties with the host institution and national programs; and maximizing
resources for NIH-funded research.
The California National Primate Research Center (CNPRC) is submitting an Alterations and Renovations
proposal for the Administrative Supplements related to high priority topics in AIDS research. This application
will be for facility renovation for an Infectious Disease/SIV Surgery Suite and Surgery Preparation Room.
The CNPRC has a strong program in Infectious Disease led by Dr. Koen VanRompay. The major emphasis
of is the SIV model with active research in therapeutics, vaccine development, and co-morbidities of HIV-
infected patients.
The proposed project is for the purchase and installation of HVAC equipment. Cost increases resulted in this
equipment not being supported by the original award. Funds are also included for purchase of equipment for
the surgical suite.
This funds requested will complete this renovation will enhance HIV/AIDs research at the CNPRC by providing
1. A sterile survival surgery suite dedicated to NIH funded investigators conducting HIV/AIDs research
2. An adjacent surgery preparation and procedure room for minor surgical procedures, endoscopy, and
CSF sampling in SIV infected animals
3. New support space to conduct pulmonary function testing in SIV infected animals as part of
interdisciplinary studies in HIV/AIDs co-morbities

Public health relevance
Narrative This alteration and renovation project is proposing the purchase and installation of HVAC and surgical equipment for the completion of an ongoing renovation of an existing building, Building 184, at the CNPRC. This simian AIDS survival surgery suite will support a wide range of CNPRC SIV research programs.